Thalamic Coordinated Reset Deep Brain Stimulation for Upper Extremity Essential Tremor: Proof of Principle Study

PROJECT SUMMARY/ABSTRACT
Essential tremor (ET) is a common neurologic disorder affecting over 10 million people in the United States.
Pathologic synchrony in the cerebello-thalamo-cortical (CTC) network has been considered to underlie the
development of ET. Traditional high frequency isochronal deep brain stimulation (T-DBS) in the ventral
intermediate nucleus (VIM) of the thalamus has been an effective treatment for ET, however, stimulation related
side effects such as dysarthria and ataxia occur in at least 30% of patients. Current spread into unintended brain
areas has been considered to underlie most observed side effects related to stimulation. Moreover, habituation,
defined as loss of effect despite optimal programming, has been reported in 30-50% of patients. The cause of
habituation to DBS is still unclear, however, it may reflect resynchronization in the CTC network. Coordinated
reset (CR) stimulation is a novel DBS approach developed to counteract abnormal synchronization in the
neuronal network which can address these issues. By using lower current amplitudes and alternating stimulation
across multiple contacts of the DBS lead, CR-DBS has been shown in Parkinson’s disease patients to produce
acute therapeutic effects comparable to T-DBS as well as carryover benefits that persist for days or weeks after
cessation of stimulation. Using lower stimulation current, CR-DBS in the VIM has the potential to minimize side
effects from current spread to adjacent structures/pathways and maintain therapeutic efficacy. As a chronic
animal model of ET is not available, evaluating the effect of VIM CR-DBS on ET preclinically is not feasible and
its effect in patients with ET has never been assessed. The goal of this study is to evaluate the feasibility, safety
and efficacy of VIM CR-DBS as a treatment for ET patients, with CR cycle rate and stimulation contacts
determined based on the physiological features of tremor related VIM activity. To achieve this goal, we will (1)
identify the peak frequency and spatial location of tremor related oscillatory activities in VIM and use these data
to guide the selection of CR cycle rate and stimulation contacts, (2) compare the effects of VIM CR-DBS to
clinically optimized T-DBS, and (3) characterize the carryover effect of VIM CR-DBS. The findings from this study
will provide proof of concept as to the safety and efficacy of CR-DBS as a novel treatment for ET. An
understanding of the carryover effect will help determine the dosing schedule of CR-DBS (delivered continuously
or intermittently) in future CR studies. If successful the results of this study will significantly advance the
development of CR-DBS for the treatment of ET, minimize side effects and potentially reduce habituation,
ultimately leading to improved clinical outcomes and a better quality of life for ET patients undergoing VIM DBS.

Public health relevance
PROJECT NARRATIVE Deep brain stimulation (DBS) is a surgical procedure for the treatment of Essential Tremor (ET). A novel approach to current DBS approaches is called coordinated reset DBS (CR-DBS) which uses different patterns of stimulation at lower currents and can address the limitations of traditional DBS that uses continuous high amplitude, high frequency stimulation. This study will evaluate the feasibility, safety and short-term efficacy of thalamic CR-DBS in upper extremity ET.